Microenvironment on Demand (MOD): A platform for single-cell cytotoxicity assays

ABSTRACT
Scribe Biosciences are leading experts in the field of droplet microfluidics and have developed a best-in-class
droplet manipulation platform, Microenvironment on Demand (MOD), that can currently assemble more than
100k paired-cell assays in under 3 hours, with proven proof of concept. Using this innovative technology, this
SBIR Phase 1 project proposes the development of a new functional screening platform that builds single-cell
combinatorial assays to be used for workflows for cell therapy candidates, to be tested here with CAR T cells.
The development of such a platform to reliably, consistently, and repeatably interrogate the activity of single CAR
T cells would answer a significant research need: Currently, even though CAR T cell-based therapeutics is the
largest category of immune-oncology agents under clinical development, there are considerable knowledge gaps
regarding many key mechanisms governing their activity, compounded by limited industry-standard candidate
discovery methods (bulk averages across an assay) which do not provide adequate information on important
factors. MOD represents an evolutionary advancement in the capability to build droplet-based cell assays with
precision and scale, effectively integrating assay construction, readouts, hit selection, and sample prep into a
single workflow and instrument. MOD co-encapsulates effector and target cells in the same microfluidic droplet,
easing identification of cytotoxic effector cells, and utilizes flow cytometry-style detection and sorting, so it is
readily scalable for high throughput. The approach for this project has been informed by previous work
developing assays on the MOD platform. Bulk interaction studies will be used to study cell killing kinetics and
different assay reagents; results will be used to build robust cytotoxicity droplet-based screening assays for
several model systems and quantify their performance. Natural killer (NK) cells and cytotoxic T-cells will be used,
specifically NK92MI (IL-2 independent NK cell line) with K562 targets and anti-CD19 CAR-Ts with (CD19+) Nalm
6 targets. The second aim will seek to understand the sensitivity of the MOD assay workflow by benchmarking
the droplet assay systems using spike-in experiments, using a cell system and assay reagent suitable for fast
cell killing and slow killing assays (tested separately). The limits of the technology will be characterized as the
relative amount of effector-cell containing droplets is incrementally reduced from 25% to1%. By building out
assays for both fast and slow cell killing, the technology will be ready to be applied to many different interacting
cell systems. Success of this functional screen assay will be determined by detection and sorting 10 hits of target
cell killing by a 1% effector cell spike-in in both models, and will enable advancement to a Phase 2 study with
diverse libraries and genomic integration. Successful MOD-enabled cytotoxicity assays could create a new
paradigm in the type of specific data that can be extracted from interaction assays, and would significantly ease
the identification of superior CAR T cell products with enhanced potency and persistence to improve efficacy
and durability, and increase the breadth of treatable malignancies.

Public health relevance
NARRATIVE The innovative technology advanced in this project is based on droplet microfluids, and performs the assembly, analysis and sorting of single cell assays with precision and scale. This project focuses on CAR T cells as therapeutics for various cancers, and the platform would be used to more efficiently screen and discover new candidates for immunotherapy, which would have a significant impact on the range of treatable malignancies. By simplifying and accelerating the screening of immune cell libraries against target cells, this platform will create a cheaper and faster therapeutics discovery pipeline.